Project 3: InHANCE: Fibrosis Imaging Biomarkers of Radiation: An Orphan Drug Study to Evaluate REduction of SeVERity of Symptoms in a Randomized Evaluative Trial (FIBRO2SE-REVERSE)

ABSTRACT: Project 3
Head and neck cancer accounts for approximately 65,000 new cancer cases and results in 13,000 deaths
annually in the United States. Recently, the incidence of human papilloma virus (HPV) associated oropharyngeal
cancer (OPC) began to increase with more than 30,000 estimated cases annually. Recent efforts to reduce side
effects through reduction of therapeutic intensity by either altering concurrent chemotherapy regimens (RTOG
1016) or removing chemotherapy entirely (NRG HN-002) have proven ineffective, such that, for the foreseeable
future, radiotherapy with or without concurrent cisplatin will remain a standard of care for non-metastatic disease.
Recent data suggest that the majority of survivors may experience moderate-to-severe lymphedema/fibrosis,
and almost half of patients may have fibrosis-associated dysphagia. Lymphedema after radiotherapy gradually
evolves from a potentially reversible stage to permanent fibrotic changes, and at present, is crudely monitored
using time- and expertise-intensive observer-rated physical palpation and endoscopic examination scales.
This study aims to address the significant public health burden of radiation lymphedema/fibrosis with a
randomized controlled basket “pick-the-winner” study of previously human-piloted FDA-approved orphan drugs
using three candidate agents with antifibrotic properties in a Phase II Bayesian trial, while simultaneously
embedding imaging biomarker assessment of quantitative MRI relaxometry for muscle fibrosis. Additionally, we
plan to develop and validate deep learning-based anatomic imaging measures to quantify and monitor
lymphedema/fibrosis clinically using MRI techniques. These strategies, if successful, will define one or more
definitive pragmatic drug regimen(s) to mitigate a quality of life altering orphan disease, and address a current
unmet need in head and neck cancer survivorship, as it affords potential pharmacotherapeutic reduction in
lymphedema/fibrosis using readily accessible agents with integrated therapeutic image-based monitoring that is
currently not possible with existing technologies.

Public health relevance
NARRATIVE: Project 3 This project addresses the critical challenge of managing post-therapy radiation-induced lymphedema and fibrosis in head and neck cancer patients, conditions that significantly impact quality of life by leading to debilitating dysphagia and trismus. It aims to assess the effectiveness of off-label FDA-approved drugs in reversing late-stage fibrosis through a Phase II pragmatic trial, alongside the development of innovative deep learning methods to quantify the severity of lymphedema and fibrosis using MRI imaging, in addition to biomarker validation of MRI relaxometry for monitoring radiation-induced swallowing muscle fibrosis.